Alterations and Renovation

Summary for Alterations and Renovations. The major objective of The Center for Pre-Clinical Cancer Research (Cancer COBRE) is to identify clinically relevant mechanisms of human cancer using models that closely reflect the disease state in the context of the tumor microenvironment. To enhance the efforts to create the center, we will establish the Pre-Clinical Evaluation Core (PCEC) to provide scientific expertise and technical support for the PJI projects. The proposed PCEC will be located in Room 2202 on the second floor of the LSU School of Veterinary Medicine (LSU SVM). The goal of the proposed renovation project is to provide a dedicated space for the PCEC Core which will centralize the advanced preclinical research expertise and state-of-the-art instrumentation for the use by the PJIs to perform proposed studies in this application. The renovation will facilitate the development of a centralized, standardized and optimized resource center for the Cancer COBRE. This will be accomplished under the following aims: Aim 1: To build a dedicated Pre-Clinical Evaluation Core facility for the COBRE in order to increase the efficiency of advanced preclinical evaluation of human cancer models and to enhance and foster collaboration among PJIs and the research community. Aim 2: To renovate the existing Room 2202 to provide technical expertise for advanced cancer cell culture systems and state-of-the-art instrumentation for use by the PJIs of this proposal and other investigators in the COBRE program.